Elucidation of the Development and Function of the Cardiac Conduction System

PROJECT SUMMARY/ABSTRACT
This five-year proposal will provide a platform for Dr. Goodyer’s successful transition to an independent
physician scientist investigating novel mechanisms for the prevention and treatment of cardiac rhythm
disorders. Specific mentorship and training opportunities have been tailored to build on the foundation of the
applicant. Dr. Goodyer will be mentored by Dr. Sean M. Wu, Associate Professor of Medicine and Pediatrics
and Dr. Anne Dubin, Professor of Pediatrics, Section Chief of Pediatric Electrophysiology (EP). Additionally, an
outstanding advisory team of internationally-renowned scientists has been selected, each advisor with unique
experiences and skillsets in fields ranging from basic science EP to translational medicine. Dr. Goodyer’s
training plan lays out a personalized program for developing his proficiency in the following key areas: 1. Use
of human induced pluripotent stem cells (hiPSCs) to functionally evaluate novel cardiac conduction system
(CCS) genes; 2. Small animal phenotyping skills for in vivo analyses of CCS development and function; 3.
Knowledge and techniques in basic science EP; and, 4. Professional development including leadership, grant
writing and science communication skills. The training plan includes experiences from Stanford courses on
stem cell research (eg. STEMREM 201B: Stem Cells and Human Development), weekly seminars on
cardiology and translational medicine, renowned workshops on leadership and communication as well as a
tailored externship focused on advanced basic science EP techniques in the lab of advisor Dr. Chiamvimonvat,
Professor of Cardiovascular Medicine at University of California Davis. These mentorship and training activities
are tailored to enable the candidate to achieve specific research goals aimed at the elucidation of CCS
development and function. In Aim 1, Dr. Goodyer will investigate the role of a novel, intracellular, CCS-specific
gene Cpne5 (copine 5), uncovered in his recently published work in Circulation Research and associated
with human heart rate variation by independent genome wide association studies. The applicant will evaluate
the function of Cpne5 in conduction cells by performing in vitro loss- and gain-of-function assays using both
isolated mouse and hiPSC-derived CCS cells. In Aim 2, the candidate will further investigate Cpne5 in the
context of CCS development and disease in vivo by comprehensive cardiac and electrophysiological
phenotyping of CRISPR-Cas9 generated Cpne5 systemic knockout mice. Finally, Aim 3 capitalizes on the
applicant’s recent discovery of another previously unknown CCS-specific marker. Specifically, by targeting this
cell surface marker the applicant will validate the use of a novel antibody-based optical imaging method for
visualizing the CCS in human hearts ex vivo. These studies will provide a proof-of-principle for the in vivo
labeling of cardiac substructures and lay the foundation for translational opportunities in the real-time
visualization of the CCS during cardiac interventions to prevent accidental intraoperative damage to the CCS.

Public health relevance
PROJECT NARRATIVE Coordinated beating of the heart relies on specialized heart cells known as the cardiac conduction system (CCS). Damage to this system can result in a host of diseases including life-threatening arrhythmias. The proposed research will examine the mechanisms underlying CCS development and function, creating translational opportunities aimed at the prevention and treatment of cardiac rhythm disorders.